MicroRNA-10a in Airway Smooth Muscle and Asthma

PROJECT SUMMARY Over 300 million people, many of them children, suffer from asthma. Airway smooth muscle (ASM) controls airway narrowing and plays a pivotal role in the pathogenesis of asthma. Asthmatic ASM becomes hyper-proliferative, secretes more inflammatory cytokines/chemokines and may be more contractile. These phenotypic changes in ASM contribute directly to airway remodeling and airway hyperresponsiveness (AHR)—cardinal features of asthma. Despite extensive studies on the regulatory mechanisms governing ASM phenotypes, no single gene or pathway is known to control multiple ASM phenotypes. Consequently, mainstay asthma therapies reduce either ASM contractility (β-agonists) or airway inflammation (glucocorticoids), and there is no therapy that directly targets ASM proliferation. MicroRNAs are small yet powerful gene tuners: a single microRNA is capable of targeting a multitude of genes and thus has the potential to impact diverse cellular processes. We recently identified miR-10a as a highly ASM- enriched and the most abundant microRNA—accounting for more than 20% of total microRNA expression in the ASM. We have reported that miR-10a inhibits the proliferation of ASM cells by directly targeting PI3KCA--the central component of the PI3K pathway. Preliminary data indicate that miR-10a also suppresses NFκB signaling while increasing the expression of β2-adrenergic receptor (β2AR)—the target of mainstay asthma drug β-agonists. Importantly, miR-10a expression is reduced in asthmatic ASM cells and by inflammatory cytokines. Based on these studies, we hypothesize that miR-10a regulates multiple critical ASM phenotypes via suppression of specific target genes and that perturbation of this regulation contributes to the development of asthma and alters response to asthma therapies. To test this hypothesis, we propose this highly integrative project that combines in vivo mouse models, molecular mechanistic studies in primary ASM cells, and genetic epidemiology in human asthma populations. Aim 1 will determine whether miR-10a inhibits AHR by suppressing ASM proliferation and chemokine secretion. Aim 2 will investigate whether that miR-10a augments bronchoprotection by inhibiting β2AR downregulation. Aim 3 will determine the association and function of miR-10a and target gene variants in asthma and in the response to asthma therapy. Results from this study will establish miR-10a as a master regulator of multiple critical ASM phenotypes and identify microRNA-10a as a novel therapeutic target for asthma.

Public health relevance
PROJECT NARRATIVE Millions of patients, many of them young children, suffer from asthma with less than optimal therapeutic options. The research is studying how a small RNA gene tuner regulates multiple functions of airway smooth muscle cells, which wrap around the airways and contribute to airway flow limitation and asthma. Our study may ultimately contribute to the development of novel small RNA-based therapy for asthma.